Structural and dynamic studies of protein and protein-nucleic acid assemblies in health and disease

PROJECT SUMMARY
Large protein and protein-nucleic acid complexes and assemblies play key roles in human health and disease,
and understanding their three-dimensional structures, conformational dynamics and interactions at the atomistic
level is essential for understanding their function and associated biological mechanisms. High-resolution
structural and dynamic studies of such large biomacromolecular systems have generally come with significant
challenges due to their inherently complex nature. However, by integrating the most recent advances in
experimental and computational methodologies many of these obstacles can now be overcome. We develop
and apply advanced spectroscopic and microscopic techniques, most notably multidimensional magic-angle
spinning solid-state nuclear magnetic resonance and cryo-electron microscopy, in combination with
complementary biochemical, biophysical and computational approaches to provide atomic-resolution insights
into the structure, dynamics, interactions and function of large protein and protein-DNA systems of major
significance in biology. The systems of primary interest in our studies include: (i) nucleosomes and large
nucleosome arrays mimicking chromatin, a supramolecular complex of DNA with histone proteins that regulates
essential genome functions such as transcription, replication and repair through dynamic changes in its structure,
and their complexes with chromatin-binding proteins and (ii) filamentous amyloids formed by mammalian
Y145Stop prion protein variants that exhibit strain and cross-seeding barrier phenomena akin to those that
underlie the pathogenesis of prion and other neurodegenerative diseases. For chromatin and its complexes we
aim to provide quantitative information on functionally-relevant conformational dynamics of histone tail and
globular domains as a function of different chromatin parameters including nucleosome positioning and post-
translational modifications, which modulate nucleosome plasticity and gene activity, and histone protein
interactions with two representative chromatin-binding proteins including a histone reader corresponding to the
histone acetyltransferase and ZZ-type zinc finger domains of human p300 and a yeast pioneer transcription
factor Cbf1. Combined, these studies will advance the atomic level understanding of critical events that regulate
gene transcription. For mammalian Y145Stop prion protein amyloids our studies will decipher the structural basis
of amyloid strains and species- and strain-dependent cross-seeding barriers with atomic level detail and furnish
insights into the impact of specific Gerstmann-Straussler-Scheinker disease linked amino acid mutations on the
core structure of Y145Stop prion protein amyloid fibrils. Collectively, the insights provided by these studies have
significant implications for the understanding of prion strains and seeding barriers, prion conformational switching
and prion strain selection, which are all of fundamental importance in the pathogenesis of prion and other
neurodegenerative disorders.

Public health relevance
PROJECT NARRATIVE Large supramolecular protein and protein-nucleic acid assemblies play key roles in human health and disease, and knowledge of their structures, dynamics and interactions is essential for understanding biological mechanism and function and for designing therapeutics. Our studies will provide atomic resolution structural and dynamic insights for large amyloid and chromatin assemblies by using an integrated approach centered on advanced spectroscopic and microscopic techniques. These studies will advance the understanding of molecular mechanisms underlying prion and amyloid propagation in neurodegenerative diseases as well as gene regulation and tumorigenesis, which is of major importance for public health.